DartCF: The Dartmouth Cystic Fibrosis Research Center

In cystic fibrosis (CF), mutations of the cystic fibrosis transmembrane conductance regulator (CFTR) unleash a
cascade of clinical disorders, including chronic airway infections, systemic inflammation, microbial virulence,
diabetes, malnutrition, and kidney and liver disease. Great progress has been made in some areas of disease,
and CFTR modulators provide dramatic benefits to many people with CF (pwCF). Still, there is growing evidence
of the interconnections among lung and gut dysbioses and CF pathogenesis. As pwCF live longer, formerly rare
symptoms are becoming more common. Thus, there is a pressing need to both understand and systematically
treat the functional relationships between CFTR function, commensal and pathogenic microbes, metabolic
states, epithelial function and immune responses. Dartmouth has an interactive CF research team of 49 faculty
members with extramural funding of $14.4M/year, studying epithelial biology, CFTR correction, host-microbe
interactions, gut dysbiosis and systemic immunity, as well as airway infections and antimicrobial strategies. The
Dartmouth CF Research Center (DartCF) will build on progress made in the past six years. We will deploy
P30 and institutional funds to recruit new CF faculty, strengthen our research base, and foster interdisciplinary
discovery. Our aims are: 1) to catalyze new research in CF basic and translational research in areas of interest
to NIDDK; 2) to develop integrative strategies to understand and address CF pathobiology; 3) to create new
research tools and support CF research through outstanding shared services; and 4) to build research capacity
in CF locally, regionally, and nationally. We will focus P30 resources on 1) forging collaborations between CF
and data-science researchers to mine CF datasets for systems-level perspectives, 2) expanding access to
sophisticated GI model systems, and 3) building on unique Dartmouth longitudinal patient cohorts to explore
microbial community structure in the gut, host-microbe signaling, the effects of existing therapies, and
implications for whole-body disease. A key theme is that dysbioses are interconnected, and that parallel
investigations, coupled by powerful new data-science strategies can understand this complex underlying biology
and reveal new therapeutic approaches. In parallel, we will leverage our research base to investigate extra-
pulmonary CF disease and treatments. DartCF supports a variety of mechanisms. First, we fund a Pilot Project
Program (P3) to develop new scientific opportunities in NIDDK-relevant areas and to recruit new faculty members
to the Center. Second, we fund three scientific cores to support studies in CF: a Gastrointestinal Model Systems
Core (GI-MSC), a Clinical and Translational Research Core (CTRC), and a CF Bioinformatics & Biostatistics
Core (CF-BBC). Finally, we support an Enrichment and Research Administration Core (ERAC) to foster an
interactive scientific community, sponsor retreats and courses, and track program progress. These efforts will
identify new CF therapeutic opportunities, develop novel interventions, monitor the resulting changes body-wide,
and track outcomes. DartCF will intensify the translation of research into improved CF outcomes at Dartmouth.

Public health relevance
Cystic fibrosis is a devastating genetic disease that involves multiple organ systems and leads to premature death; therapeutic advances have extended lifespans and improved quality of life, but patients still suffer from CF-related diabetes, digestive complications, and inflammatory responses, in addition to airway infections. Our Center catalyzes new research in gut and kidney disease, diabetes, changes in patient microbiomes, systemic immunity, and preclinical drug development. We believe that these phenomena are interconnected, and that parallel investigations, coupled by powerful new data-science strategies can find new therapeutic approaches for CF patients by understanding the complex underlying biology.